Population Research Center

OVERALL: PROJECT SUMMARY
The Population Research Center (PRC) at the University of Texas at Austin (UT) seeks to renew our P2C
infrastructure funding to continue successful programs and launch new initiatives that will catalyze the next
generation of population dynamics research regarding the social, structural, and contextual processes
underlying population health and health disparities. The PRC serves its faculty scholars through three
established and efficient Cores: An Administrative Core, a Development Core, and a Scientific and Technical
Core. The work of the PRC will be organized around five specific aims: (1) To advance and innovate
population dynamics research through the cultivation of a collaborative and productive intellectual community;
(2) To assist PRC’s faculty scholars in successfully competing for external funding; (3) To provide mentoring,
scaffolding, and prioritization of services that enable Early Stage Investigators to conduct cutting-edge
research and ultimately to achieve research independence; (4) To deliver timely, efficient, and effective pre-
award and post-award administration, computing technology, and statistical supports that allow PRC faculty
scholars to successfully conduct, and disseminate, impactful population dynamics research; and (5) To share
P2C-enabled resources with research community members at other institutions across Texas. PRC faculty
scholars are leading experts in the center’s four Primary Research Areas: Population Health and Well-Being;
Reproductive, Maternal, and Infant Health; Family Demography and Human Development; and Education,
Work, and Institutions. The activities and supports provided by the P2C infrastructure funding will allow PRC
faculty scholars to continue to advance the field’s understanding of what factors promote population health and
what factors undermine health and increase health inequities.

Public health relevance
OVERALL: PROJECT NARRATIVE With infrastructure support from the Population Dynamics Branch of NICHD, the Population Research Center at The University of Texas at Austin aims to advance public health understanding of the social, structural, and contextual processes underlying population health and health disparities.